BGSU Administrative Core

Abstract
The Administrative Core of the Lake Erie Center for Fresh Waters and Human Health (the `Center') will
manage fundamental research and community-based projects ultimately focused on understanding and
mitigating toxic cHAB risks in Lake Erie. Western Lake Erie has been plagued with cHAB blooms for the last
decade, and recent bloom events have resulted in exposure risks that led to the complete shutdown of the
Toledo (OH) water supply in 2014. The Administrative Core is focused on supporting and coordinating four
integrated research projects, a Community Engagement Core and a Facilities Core to ensure progress toward
our stated goals of understanding and communicating climate change effects on cHAB events and their impact
on human health in the lower Great Lakes. The Administrative Team is composed of a Director and Co-
Director responsible for reporting progress and outcomes of Center activities, and will oversee the duties of the
Internal Steering Committee, whose individual roles include: research coordination, coordination of community
outreach and public policy, data management and budget management. Relevant research results and
potential policy outcomes will be communicated to state agencies and NGOs as they emerge. The
Administrative Team will be assessed by an External Advisory Committee, staffed by scientists outside of the
participating institutions, as well as representative from state agencies and NGOs. Communication from the
Center with other OHH Centers will promote collaboration and data sharing where appropriate.